BASIC RESEARCH IN PERSONALITY

Personality can be defined in terms of enduring individual differences in emotional, interpersonal, experiential, and motivational styles. The five factors of Neuroticism, Extraversion, Openness to Experience, Agreeableness, and Conscientiousness provide a comprehensive taxonomy of personality traits for the description of personality in aging men and women. Two studies examined issues in personality structure. In the first, the five-factor structure of the NEO-PI-R was shown to be replicable in Chinese and Japanese data; in the second, positive and negative valence were located in the five-factor space.